PRISM: Ethically-guided multimodal AI models for predicting disease pathogenesis in individuals with pathogenic variants

PROJECT SUMMARY
This project aims to develop machine learning and artificial intelligence tools to enhance prediction of disease
manifestation in individuals with pathogenic genetic variants. We will focus on Alzheimer's disease and
cardiomyopathy, leveraging diverse data from large biobanks and healthcare systems to create a more
comprehensive and nuanced understanding of how genetic variants interact with other factors to influence
disease onset and progression. Our interdisciplinary team will create an ethical framework to guide tool
development and implementation, integrating genomic, clinical, imaging, and other data types into a common
model. We will build and validate tools to predict disease onset, progression, and treatment response. We will
then perform rigorous cross-validation to assess the generalizability of these tools across different datasets and
clinical settings, ensuring their robustness and applicability in diverse healthcare contexts. Using a combination
of advanced AI and interpretable machine learning methods, we aim to identify novel biomarkers for disease that
could be more readily translated into clinical practice. Integrated with the technical development, we will conduct
research on the ethical, legal, and social implications (ELSI) of incorporating these tools into genomic medicine.
The results of these ELSI research projects will be further integrated into our ethical framework to inform the
development of the optimal AI tools. This project will advance the field by improving risk stratification for variant
carriers and identifying factors influencing disease beyond genetics alone. We aim to disseminate validated
tools, best practices, and lessons learned to the broader research community, potentially transforming how
genetic risk is assessed and managed in clinical practice. By combining cutting-edge computational methods
with careful ethical consideration, we hope to create resources that can significantly enhance patient care and
our understanding of complex genetic diseases. Ultimately, this work will lead to more targeted prevention
strategies, personalized treatment plans, and improved outcomes for individuals at risk of Alzheimer's disease,
cardiomyopathy, and other genetically influenced conditions.

Public health relevance
PROJECT NARRATIVE This research aims to develop advanced computational tools that can better predict and understand how and when individuals with genetic variations develop diseases like Alzheimer's and cardiomyopathy. By combining genetic information with other health data and considering ethical implications, we seek to improve our understanding of disease progression and create more personalized approaches to prevention and treatment. Ultimately, this work could lead to earlier interventions, more effective therapies, and improved health outcomes for individuals at risk of genetically influenced diseases.